Toward a mechanistic understanding of genetic interactions

A key challenge of the post-genomic era is the functional interpretation of the vast numbers of single nucleotide variants
found in human genomes. This challenge is compounded by the fact that these variants contribute to complex traits and
diseases by interacting with one another and with genetic variation in repetitive DNA elements. Assessing the phenotypic
consequences of all genetic interactions amounts to an impossible numbers game. In order to prioritize certain variant
combinations, I will use model organisms with powerful genetics, namely the yeast S. cerevisiae and the worm C.
elegans, to identify and characterize genetic interactions with large impact on complex phenotypes. I propose three
projects that capitalize on our previous studies. These projects are united by their focus on genetic interactions (i.e.
epistasis), albeit they address different types of variant combinations and different mechanisms. The first project focuses
on rDNA, a highly variable repetitive DNA element. Variation in rDNA copy number impacts gene expression,
replication, genome stability, and mitochondrial abundance. Like other repetitive loci, rDNA is predisposed to interact
epistatically with other variants because of its high mutation rate. Using newly developed C. elegans mapping populations
and robotics-enabled phenotyping, our preliminary data show that rDNA copy number variation affects lifespan and
fitness through epistasis. High-throughput analyses of healthspan traits such as stress resistance and fertility are ongoing.
We will pursue fine-mapping of the most significant genomic loci implicated in epistasis with rDNA because their
identity, possibly DNA replication or repair genes, may point to the molecular mechanism by which rDNA variation
affects phenotype. In both yeast and worms, we will use the entire tool box of genetics and genomics to directly
interrogate the pathways by which rDNA copy number variation affects replication, genome stability, and mitochondrial
abundance. To enable accurate high-throughput measurements of rDNA copy number in model organisms and humans,
we will optimize a promising FISH technology. The second project relies on the detailed genotype–phenotype maps we
established for genes in the yeast mating pathway. Selecting single nucleotide variants of small and intermediate effects,
we will combine variants in two genes and test the combinations for mating efficiency while also perturbing strong
genetic modifiers and applying common stresses. To do so, we developed a sequencing strategy that allows us to
simultaneously phenotype tens of thousands of single nucleotide variant combinations between pairs of genes. The third
project will apply a technology of dominant negative polypeptides that we recently developed to identify at genome scale
protein interaction surfaces and their dynamics. In yeast, we will explore to what extent genetic interactions reflect direct
protein interactions. We will ask how easily (or not) protein interaction surfaces are perturbed by mutation, by
evolutionary divergence, or by drugs or stress that perturb protein folding. Together, the results of these three projects will
yield a broad and deep assessment of epistasis, testable hypotheses for human genetics and novel technologies for testing
them.

Public health relevance
Recent sequencing efforts have identified hundreds of millions of single nucleotide variants in human genomes that contribute to complex traits and diseases by interacting with one another and with genetic variation in repetitive DNA elements. The challenge of functionally interpreting this vast amount of variation is formidable: even considering only gene deletions, >108 and >1012 combinations for all 2-and 3-way interactions in the human genome would need to be tested. To reduce the complexity of variant combinations, we use genetically tractable model organisms and cutting-edge technologies to rigorously assess the various types of genetic interactions and to identify those with the most impact on phenotype, thereby generating both testable hypotheses for human genetics and novel technologies for testing them.